Function of calcium-activated small conductance potassium channel in astrocytes

ABSTRACT
Astrocytes express abundant voltage-independent leak-type K+ channels to make the membrane highly
permeable to K+ ions and to have a hyperpolarizing membrane potential. These are two requisites for astrocyte
function in brain homeostasis. The leak K+ channels generate a characteristic ohmic behavior, commonly called
passive, K+ conductance in astrocytes. While the research over the past decades identified several inwardly
rectifying K+ channels, such as Kir4.1, to contribute to passive K+ conductance, the molecular identity of a major
leak K+ channel, a K+ channel that follows the Goldman-Hodgkin-Katz (GHK) equation to show constant field
outward rectification, remains elusive. This proposal aims to solve this longstanding puzzle by examining the
functional expression of a small conductance Ca2+-activated K+ channel, SK2 (KCNN2), as a GHK rectifier K+
channel, in astrocytes. Further, this proposal will examine the interaction of SK2 with adrenergic signaling for
dynamic regulation of astrocyte passive K+ conductance. The premise underpinning this proposal includes a high
expression of SK2 mRNA in freshly dissociated hippocampal astrocytes, the presence of a large portion of
passive K+ conductance that is sensitive to a highly selective SK2 inhibitor, apamin, and responsiveness of
astrocyte passive K+ conductance to Gq-coupled adrenergic a1 receptor (a1-AR), known to be expressed by
astrocytes. These observations compellingly show the SK2 as the long-sought GHK rectifier K+ channel engaged
in astrocyte passive K+ conductance. Extending from these preliminary studies, this proposal aims to achieve
three specific objectives. First, to correlate the apamin-sensitive passive K+ conductance with the SK2 channel
gene (Kcnn2) through inducible astrocytic Kcnn2 knockout (Aldh1l1-Cre/ERT2;Kcnn2fl/fl;Ai9). Second, to validate
the observation that Kir4.1 and SK2 work in concert to generate astrocyte passive K+ conductance through
inducible Kcnj10/Kcnn2 double gene knockout from astrocytes (Aldh1l1- Cre/ERT2;Kcnn2fl/fl;Kcnj10fl/fl;Ai9). Third,
to test a hypothesis that adrenergic signaling modulates K+ passive conductance through the interaction of
astrocytic a1-AR and SK2. This project will for the first time correlate SK2 to the long-sought for GHK rectifier K+
channel in astrocyte passive K+ conductance. The results of the interaction of SK2 with adrenergic signaling
have the potential to vertically change the “passive” view of astrocyte K+ conductance in brain homeostatic
function. Second, through comparative analyses of SK2 and Kir4.1 KO astrocytes, we expect an outcome that
would advance the notion that Kir4.1 and SK2 work in concert to implement the K+ uptake and release in the
process of [K+]e buffering. Third, the resultant knowledge and validated animal models from this project should
facilitate future studies of leak-type SK2 and Kir4.1 in astrocyte physiology and pathology.

Public health relevance
PROJECT NARRATIVE Astrocyte K+ channels are paramount for brain homeostasis but the entire repertoire of K+ channels in astrocytes is not fully identified. This proposal will examine the contribution of our newly identified K+ channel, a calcium- activated small K+ channel (SK2), to astrocyte membrane K+ conductance and the dynamic capacity that SK2 renders to the homeostatic function in the brain through the interaction with the adrenergic signaling with the Gq- coupled a -1 adrenergic receptor (a1-AR) expressed on astrocytes.